Aging and Alzheimer's Research Training

The Georgetown University “Aging and Alzheimer’s Research Training” (AART) program is designed for
predoctoral students and postdoctoral fellows whose backgrounds have not included substantial previous
training in aging or Alzheimer’s disease. It is driven by a transdisciplinary group of researchers across
biomedical topics that are associated with cognitive impairment with aging (e.g., diabetes, HIV-infection,
traumatic brain injury, proteinopathies, chemotherapy, seizures). The AART program will direct aspects of
these research disciplines more directly to aging and AD research through the trainees. Participating faculty
have the dedicated time and the University support to allow the AART program to thrive. Beyond this research,
there are ten general areas of required training: 1) Clinical exposures in the Memory Disorders Program and in
brain cuttings; 2) Coursework in areas of Biostatistics, Aging, and Neurodegeneration; 3) Structured personal
interactions each semester with researchers from Alzheimer’s Disease Research Centers; 4) Intensive grant
writing for current research projects and nascent careers; 5) Attendance and presentations at national
meetings; 6) A new Georgetown symposium on Aging and Alzheimer’s disease; 7) Cohort writing of a review
paper on an interdisciplinary research topic; 8) Regular training the Responsible Conduct of Research as well
as Rigor and Reproducibility; 9) Roundtables to promote thoughtful consideration of training experiences,
including research; and 10) Outreach experiences for public education and social good. As developed, several
of these required activities are specific to the AART cohorts (e.g., personal interactions with national research
leaders, instruction in writing of a publishable literature review, data presentations), and several more would
positively impact the broader Washington, DC research community (the yearly Aging and AD symposium;
research interactions with regional Alzheimer’s Disease Research Centers). Other activities ensure that
trainees benefit from current University resources (journal clubs, existing coursework, training in quantitative
and reproducible data analysis). Trainees will work with the Office of Career Strategy and Professional
Development, which will also aid in the recruitment of individuals from under-represented minority groups. The
program is directed by G. William Rebeck, who has contributed research to these areas for nearly 30 years.
Oversight is provided by an Executive Committee, and by Internal and External Advisory Boards. Georgetown
has the advantages of a cohesive set of researchers and strong financial support from the University.
Furthermore, there are resources in the Washington DC area that are unique for better training, including
researchers at the NIH/NIA, Howard University programs, and federal interactions. The goal of the AART is to
take strong existing research programs at Georgetown related to conditions of aging, and use them to train
students and fellows more intentionally in topics of aging and AD. This program will also drive these research
labs to produce impactful aging and AD research.

Public health relevance
A program in Aging and Alzheimer’s Research Training (AART) at Georgetown University will train PhD students and postdoctoral fellows in laboratory research into causes and connections of aging-related neurodegenerative diseases. The program will build on a wide array of current research laboratories at Georgetown University in aging and neurodegeneration, on clinical and neuropathological programs, on graduate aging coursework, on regional centers of aging and Alzheimer’s disease, and on a dynamic office for career development. The overall goal is to train students and fellows whose current research experience is related to, but not focused on, aging and Alzheimer’s disease research, and to foster advances in aging/AD research by promoting this interdisciplinary work.